Functional Consequences of Histone H2B Variants in Driving Oncogenic Phenotypes

Project Summary
Histone proteins are the basic packaging unit of DNA. They comprise a hetero-octamer protein complex around
which DNA is wound, and are compacted into chromatin. Histone proteins also play a critical role in regulating
gene expression; however, missense mutations in genes encoding histone proteins, referred to as oncohistones,
drive cancers. Although the majority of characterized oncohistones occur in histone H3, mutations in other
histone genes can also drive cancer. Histone residues that support post-translational modification have also
been shown to regulate DNA damage repair. Missense mutations to these residues could disrupt these pathways
and potentially impact how cancer cells respond to DNA-damaging therapeutics, such as radiation. Through the
analysis of publicly available tumor genomic data, I have identified five histone H2B variants that recur in patient
tumors. Like the most extensively characterized H2B oncohistone, H2BE76K, these variants occur in various
cancer types, including solid cancers and hematological malignancies such as Non-Hodgkin Lymphoma (NHL),
making human mammary epithelial cells and Ramos cells, a transformed cell line modeling NHL, relevant models
in which to characterize the functional impact of these mutations. I hypothesize that novel cancer-associated
histone H2B variants can drive oncogenic phenotypes and alter cellular responses to DNA damage. To examine
the oncogenic potential of cancer-associated H2B variants, I have engineered human cell lines expressing these
H2B variants and have designed a research strategy implementing several interdisciplinary approaches that will
characterize H2B variants as putative oncohistones, and elucidate their functional impact in the DNA damage
response. The overarching goal is to test whether cancer-associated H2B variants may contribute to oncogenic
processes and explore how these H2B variants may impact cellular DNA damage response, gene expression,
and chromatin accessibility in response to DNA damage. These goals will be accomplished though two Specific
Aims. In Aim 1, I will characterize H2B variants’ impact on cancer hallmarks in vitro by assessing cell
proliferation, colony formation, migration and invasion comparing cells expressing wildtype H2B to cells
expressing the variants I have defined. I will then examine the ability of H2B variants to drive tumorigenesis using
in vivo murine xenografts. In Aim 2, I will examine how H2B variants influence cell viability after exposure to
DNA damaging agents such as irradiation and characterize DNA damage repair. I will then examine gene
expression and chromatin accessibility changes in cell lines that score in in vitro assays in the presence and
absence of DNA damage. My exciting preliminary data reveal that several of these potential oncohistone mutants
can drive pro-invasive phenotypes, providing proof of principle that the potential oncohistone mutations I have
identified confer oncogenic phenotypes. Completion of these studies will test the model that additional H2B
variants function as oncogenic drivers and provide mechanistic insight into their cancer-driving properties, which
may unmask possible therapeutic targets for H2B oncohistone-driven cancers.

Public health relevance
Project Narrative Alterations to histones, the proteins that package genomic DNA, can drive the development of cancer. The studies proposed here will test whether currently uncharacterized alterations within the histone H2B protein can drive cancer phenotypes and disrupt pathways involved in protecting the genome. Understanding how these H2B variants cause cancer can provide rationale for therapeutic development.